COBRE: OUHSC: ADMINISTRATION, MENTORING, & RECRUITMENT CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Administrative, Mentoring, and Recruitment (AMR) Core module is responsible for the fiscal and procedural management of the COBRE program. All reports related to PJI and Core modules will be prepared by the AMR. The Visiting Scholars program will be the responsibility of the AMR Core. The alterations and renovations proposed will be overseen by the AMR Core. Salaries for clerical staff and all mentors will be paid through this module. IAC and EAC meetings will be arranged by the AMR straff, who will also record minutes of each meeting and prepare written reports.